Yale Liver Center

The Yale Liver Center is one of 17 Silvio O. Conte Digestive Diseases Research Core Centers (DDRCC)
supported by NIDDK and one of only three that focus on the study of liver structure, function, and disease. The
Liver Center consists of four Core Facilities: 1) An Administrative Core; 2) A Cellular and Molecular Physiology
Core; 3) A Morphology Core and 4) A Clinical-Translational Core. The research base focuses on three major
basic/translational themes: (1) Hepatic metabolism, (2) Immunobiology and inflammation, and (3) Epithelial
biology/pathobiology. The research programs range from fundamental studies of liver biology to translational
studies of immediate clinical relevance. Major areas of liver disease examined within these themes include
autoimmune diseases, cholestasis, fibrosis/cirrhosis, genetic diseases, infections, liver cancer, and
MASLD/AALD. The major goals of the Center are: (1) to stimulate multidisciplinary interactions between basic
and clinical faculty and departments, (2) to provide an in-depth training environment, (3) to efficiently organize
time consuming, often costly techniques and procedures in Core Facilities for use by multiple investigators, (4)
to stimulate basic scientists to direct their focus to areas of interest to the Center, (5) to stimulate translational
research from bench to bedside, (6) to promote new research and training opportunities with a pilot feasibility
program, and (7) to create an intellectual environment within the field by fostering collaborations both within and
outside the institution through its enrichment program. As part of the Center’s enrichment program, we plan to
host a scientific symposium for early-stage investigators pursuing digestive disease research concurrently with
hosting the 2024 Annual DDRCC meeting. This program format will be like recent past meetings, including Univ.
Penn (2018), UCSF (2020), MUSC (2022), and most recently Cincinnati (2023). Because the DDRCC program
is dedicated to fostering the growth of early-stage investigators, these scientists will be a targeted audience of
the symposium. Thirty-two early career scientists (two from each of the other 16 DDRCCs) will be subsidized to
attend the event and participate by presenting their liver/digestive disease work as either an oral or poster
presentation. Six investigators or approximately 20% will be selected based on their submitted abstracts to
present their work as an oral presentation. The symposium will include opportunities for career development,
mentoring and networking opportunities for the early-stage investigators. The DDRCC meeting also will focus on
fostering collaborations among centers, sharing best practices for leading a successful center, and enhancing
diversity and inclusion. All attendees will have an opportunity to learn about the cutting-edge liver/digestive
disease scientific programs and research core technology services that are available at the Yale DDRCC as well
as the other 16 centers. We are requesting an administrative supplement to project number P30 DK034989 to
organize and host the meeting/symposium. Funds will be used to secure a venue, organize the meeting and
offset travel expenses for invited speakers and early-stage investigators.

Public health relevance
PROJECT NARRATIVE The Yale Liver Center is one of 17 Silvio O. Conte Digestive Diseases Research Core Centers (DDRCC) supported by the NIH/NIDDK and one of only three that focus on the study of liver structure, function, and disease. This supplement application aims to support the Annual DDRCC meeting to foster collaborations among centers and a scientific symposium for early-stage investigators to present their liver or digestive disease research. The symposium will also include opportunities for scientific feedback, career development, mentoring and networking for the early-stage investigators.